Admin Supp UK - SEAL (Stopping Atopic dermatitis and ALlergy) Study: Prevent allergy by enhancing the skin barrier

Project Summary/Abstract for the SEAL (Stopping Eczema and ALlergy) Study
Parent U01 Project Summary and Abstract for the SEAL (Stopping Eczema and ALlergy) Study
Food allergy (FA) is an epidemic among children in the U.S., U.K., and other countries. There is increasing
evidence that epicutaneous allergen sensitization through a dysfunctional skin barrier results in allergic
responses whereas early consumption of food allergens induces oral tolerance, as described by the dual
allergen exposure hypothesis. In the Learning Early About Peanut LEAP and Enquiring About Tolerance
(EAT) studies, dry skin and the severity and the duration of eczema or atopic dermatitis (AD) in the 1st year
of life were predictors of peanut allergy (PA) and sensitization. In the SEAL study, we aim to intervene very
early in a high-risk infant group, as soon they have the earliest onset of dry skin or eczema in the 1st 10
weeks of life, but before they have developed allergies. By reducing the duration and severity of eczema
and preventing eczema exacerbations, we aim to prevent epicutaneous allergen sensitization and
significantly reduce the incidence of FA. Our primary objective is to test if the combination of trilipid skin
emollient use early in life with proactive topical steroids decreases the prevalence of FA compared to
controls. We propose a randomized (1:1), controlled trial design for infants with dry skin or eczema (n=750
total) to compare the effect of proactive treatment against a reactive treatment group for the prevention of
FA, by reducing dry skin, and the severity and duration of eczema in early infancy. We will test our
hypothesis with the following specific aims using world-class clinical research units known for excellent
recruitment and retention of patient cohorts, mechanistic testing, and state of the art research. Specific
Aim 1: To determine if proactive versus reactive treatment will reduce the occurrence of FA in a
prospective, randomized, and controlled intervention trial of infants with eczema. Specific Aim 2: To test
whether the skin of children in the proactive treatment will show improved epithelial barrier markers with
increased commensal bacteria colonization. Specific Aim 3: To determine whether proactive treatment will
be associated with protective immune responses. If the aims are achieved, our proposal will make a clinical
impact by providing a new, clinical strategy to prevent the occurrence of FA in young infants that present
with the earliest signs of dry skin or eczema.
Supplement Project Summary and Abstract
Food allergy (FA) is an epidemic among children in the U.S., U.K., and other countries. There is
increasing evidence that epicutaneous allergen sensitization through a dysfunctional skin barrier, results
in allergic responses whereas early consumption of food allergens induces oral tolerance, as described
by the dual allergen exposure hypothesis. In the Learning Early About Peanut (LEAP) and Enquiring
About Tolerance (EAT) studies, dry skin and the severity and the duration of eczema or atopic dermatitis
(AD) in the 1st year of life were predictors of peanut allergy (PA) and sensitization.
In the SEAL study, we aim to intervene very early in a high-risk infant group, as soon they have the
earliest onset of dry skin or eczema in the 1st 10 weeks of life, but before they have developed allergies.
By reducing the duration and severity of eczema and preventing eczema exacerbations, we aim to
prevent epicutaneous allergen sensitization and significantly reduce the incidence of FA. Our primary
objective is to test if the combination of trilipid skin emollient use early in life with proactive topical steroids
decreases the sensitization to food allergens compared to controls. We propose a randomized (1:1),
controlled trial design for infants with dry skin or eczema (approximately n=320 total) to compare the
effect of proactive treatment against a reactive treatment group for the prevention of FA, by reducing dry
skin, and the severity and duration of eczema in early infancy. We will test our hypothesis with the
following specific aims using world-class clinical research units known for excellent recruitment and
retention of patient cohorts, mechanistic testing, and state of the art research.

Public health relevance
Project Narrative for the SEAL (Stopping Eczema and ALlergy) Study Food allergy (FA) is an Epidemic among children throughout the world. The overall objective of our current SEAL (Stopping Eczema and Allergy) study is to prevent allergy by enhancing the skin barrier with proactive skin care utilizing the combination of skin emollient early in life with topical anti-inflammatory agents as required to decrease epicutaneous allergen sensitization and FA. The effectiveness of this prevention strategy will be monitored by novel measures of skin barrier function and the emergence of protective immune responses in infants and young children benefiting from our novel preventative approach.